Aberrant RBC SNO transport and endothelial adhesion in sepsis

In critically ill patients, anemia is a well-established risk factor for poor outcomes but, paradoxically, liberal RBC
transfusion in these patients does not improve outcomes as compared with a restrictive strategy in which patients
remain moderately anemic. Changes taking place very early in the storage process may contribute by impairing
RBC function. We have identified functional and biochemical changes in the first day of RBC storage that
contribute to a proadhesive effect of blood banking. Most recently, we identified a novel mechanism whereby
healthy human RBCs export the nitric oxide (NO) derivative, S-nitrosothiol (SNO), to oppose endothelial
adhesion of RBCs in vitro and in vivo in mice. This RBC SNO export is depressed after RBC storage. To study
the physiological significance of this pathway, we engineered a mouse in which the responsible SNO transporter
is inducibly deleted from endothelial cells. ECs from this mouse import SNO poorly as predicted, and RBC
adhesion is increased in the lungs of these mice after transfusion. In mice with sepsis (injurious response to
serious infection), we find that RBC export of SNO is decreased even though RBC SNO content is elevated. We
hypothesize that in sepsis, intercellular SNO transport is deficient, promoting the adhesivity of RBCs (native or
transfused) and neutrophils. We will test this hypothesis by accomplishing these Specific Aims:
1. Determine the influence of sepsis on antiadhesive SNO export from RBCs. We find that after cecal
ligation and puncture (CLP), the ability of murine RBCs to export antiadhesive SNO is deficient. We will test
whether the SNO deficiency and proadhesive effect in this sepsis model are related, such as by testing rescue
using extracellular CSNO (S-nitrosocysteine). We will test whether SNO export by one RBC population can
influence the adhesivity of other RBCs in paracrine fashion. The relevance to human sepsis in Veterans will be
tested by studying the LAT1-dependent ability of patient RBCs to export SNO basally and in hypoxia.
2. Determine the influence of LAT1-mediated SNO export on neutrophil adhesion. Neutrophil adhesion to
the endothelium is a key early event in immune responses to infection. Antiadhesive NO/SNO is abundant in
sepsis and may limit organ damage. We will determine the role of LAT1 and SNO export in modulating the
adhesivity of neutrophils. We will determine the role of RBC SNO export in modulating the adhesion of
neutrophils. We will identify the adhesion receptors and counterreceptors mediating LAT1/SNO-sensitive
neutrophil adhesion. Finally, we will determine the role of LAT1-mediated SNO export (and EC SNO import) in
the adhesivity of adoptively transferred neutrophils.
3. Determine the role of SNO export by RBCs and neutrophils in adhesion and extravasation in a mouse
model of CLP-induced sepsis. We will measure the adhesion of both RBCs and neutrophils, and indices of
organ injury, in sepsis secondary to CLP in our mice conditionally deficient in EC LAT1. We will determine the
influence in septic (post-CLP) mice of autologous or heterologous RBC transfusion as a function of SNO export
competence (LAT1 deletion or inhibitors). Given our demonstration that the proadhesive effect of RBC storage
can be mitigated by RBC renitrosylation, we will investigate the influence of RBC SNO augmentation in a mouse
model of sepsis (CLP)-induced cellular adhesion and organ injury.
Numerous supportive and other therapies have failed in sepsis, including RBC transfusion for anemia, a
clinically significant comorbidity in sepsis. Our innovative mechanistic focus on altered intercellular SNO
transport, facilitates the identification of translatable solutions made possible in the form of vehicle RBC
transfusates.

Public health relevance
RELEVANCE Sepsis, an overwhelming and adverse response of the body to infection, afflicts thousands of Veterans annually and kills millions globally each year. Antibiotics alone often do not suffice, and other therapies to treat the organ- damaging consequences of sepsis have been uniformly disappointing. Patients with sepsis frequently also have anemia, and the two conditions conspire to compromise oxygen distribution in the body, in turn aggravating the characteristic organ damage. In this project, we focus on uncovering mechanisms by which red blood cells modulate injury during sepsis. Our focus is on a newly recognized pathway for the exchange of molecules that act as signals between the blood cells and the blood vessel cells, and we will specifically test the role of molecules that can now be augmented when anemic patients with sepsis are transfused. We take advantage of a newly produced mouse model designed to unravel this newly recognized signaling molecule, and use innovative methods to visualize these processes in the capillaries in order to address this significant problem.